Metabolomics Core

PROJECT SUMMARY/ABSTRACT – CORE B
Allogenic hematopoietic stem cell transplant (allo-HCT) can provide a cure for chronic infections, genetic
diseases, or cancers of the blood. However, its therapeutic utility is limited by associated toxicities
resulting from graft versus host disease (GVHD). Among the most prominent morbidities of GVHD is
damage to the gastrointestinal tract. Recent results from our groups have revealed that the severity of
GVHD is impacted by the nature and metabolic properties of the gut microbiome. Further, we found that
promotion of microbial communities that facilitate the metabolism of starch into butyrate and reprogram
bile acid metabolism of the host ameliorate or even prevent GVDH following BMT. The measure and
quantitation of metabolism is essential to address the associated experimental aims across the
research proposals. The purpose of the Metabolomics core is to support the research projects that
build on these studies to detect and quantify metabolites from these pathways in stool from mice, bacterial
populations, human epithelial cells, and longitudinal stool samples of patients in the associated clinical
trial. Further, this core will also provide global insights into host and microbiome metabolism using stable
isotope tracing technologies and untargeted metabolome-wide profiling. By centralizing the development,
maintenance, and implementation of metabolomics methods, this core will provide state-of-the-art
capabilities to facilitate data collection and analysis while ensuring consistency across projects.